Innate Immune Responses to SARS-CoV-2 in AD mouse models

RESEARCH SUMMARY
Sudden-onset of olfactory loss has been recognized as a common COVID-19 symptom during the early phase
of the pandemic. Whether the degree of olfactory deficit in COVID-19 is indicative of any long-term
neurological diseases has not been carefully evaluated. Olfactory dysfunction is well recognized as an early
symptom of dementia, particularly in Alzheimer’s and Parkinson’s diseases. Recent human study identified that
SARS-CoV-2 infection is associated with early onset of Alzheimer’s disease. Using mouse models, we
observed expanded inflammatory responses in the olfactory epithelium upon sparse SARS-CoV-2 infection.
Widespread olfactory receptor downregulation has been reported under viral infection suggesting that there
might be a distributed viral impact from localized viral infection in the olfactory epithelium. We hypothesize that
widespread the inflammatory response in the olfactory epithelium, triggered by SARS-CoV-2, enhances the
impact of familial Alzheimer’s disease mutations resulting accelerated disease progression. In this study, we
will characterize inflammatory responses to SARS-CoV-2 in the olfactory epithelium and the olfactory bulb in
Alzheimer’s disease mouse models; and we will further determine SARS-CoV-2 infection induced olfactory
functional deficits in AD mouse models. Through this study, we will gain understanding of genetic background
dependent molecular and histological changes upon SARS-CoV-2 infection. This pilot study will also establish
premise for using olfactory pathway as an entry point to investigate the molecular mechanisms involved in
Alzheimer’s disease pathogenesis.

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease (AD) is the most common type of dementia and 5.8 million people in the US are currently living with the disease. Increasing evidence suggest that SARS-CoV-2 infection increases the risk of AD. This study aims to investigate the compound neuroinflammatory responses in the primary olfactory pathway induced by SARS-CoV-2 infection under the contribution of familial AD genetic mutations to gain understanding of risk factors for Alzheimer’s disease.